Investigating the prevalence of medical mistrust amongst pregnant and perinatal women

SUMMARY / ABSTRACT OF PARENT GRANT
Crisis pregnancy centers (CPCs) are non-profit organizations with the mission of supporting pregnant people in
not having an abortion. To this end, CPCs offer free services (e.g., urine pregnancy tests, non-diagnostic
ultrasounds, and peer counseling on a limited range of pregnancy options) and the opportunity to earn infant-
related material items by attending classes. Public funding increasingly plays an important role in CPC
functioning. In Ohio, state funding of CPCs increased from $1 million to $7.5 million in 2019. Despite
advertising the provision of health procedures and receiving state funding and endorsement, CPCs typically do
not employ medical staff and are not licensed as medical facilities. Per a recent U.S. Supreme Court case,
CPCs are not compelled to disclose that they are not medical facilities. Professional medical organizations
warn of possible health risks of CPCs; however, to date, little research has been conducted on their possible
effects. We conducted two preliminary studies in preparation for this project. First, in our population-based
survey, we found that attending a CPC is common, with 14% of women 18-45 years of age in Ohio reporting
ever CPC attendance. Attendance was more common among non-Hispanic Black people and those of low
socioeconomic status. Second, by conducting in-depth interviews with CPC staff and clients, we found that
clients often attend the CPC for pregnancy confirmation and some perceived the CPC to be a medical clinic
that provides early pregnancy care. This project seeks to quantify health-related outcomes associated with
attending a CPC and, among those attending a CPC, disparities in services received. Specifically, we will use
survey data to address three aims: 1) To assess whether delayed entry into prenatal care is more
common among people who had previously attended a CPC for the current pregnancy relative to non-
attendees; 2) To assess whether the pregnancy options counseling provided at CPCs differs by client
demographics (e.g., race/ethnicity, marital status, and religion) after controlling for client pregnancy
plans before the CPC visit; and 3) To assess the prevalence and patterns of medical mistrust among
prenatal patients overall and among the subset who attended a CPC. To address these aims, we will
survey 400 patients who recently entered into prenatal care. The sample will include 200 women who had
attended a CPC before entering into prenatal care and a comparison group of 200 women who had not
attended a CPC before entering into prenatal care. We will use frequency matching for enrollment (age and
race/ethnicity) and matching with propensity scores during the analysis to reduce bias. In addition, we will
conduct follow-up interviews with 40 participants who express medical mistrust 4) To assess racial
differences in the patterns and typology of medical mistrust. While CPC literature has been expanding in
recent years, almost no quantitative data has been published on CPC clients. We expect this project will yield
fundamental evidence on the possible consequences of CPC attendance among pregnant people.

Public health relevance
Crisis pregnancy centers (CPCs) increasingly are supported with public funding and are endorsed by the state as referral sites for family planning and care. Despite this, CPCs typically are not licensed as medical facilities. We propose conducting a survey of prenatal care patients who attended – and a comparison group of those who did not attend – a CPC before initiating prenatal care with follow up interviews to understand the risks associated with CPCs and the landscape of medical trust and health knowledge among prenatal care patients.